INSPIRE: Innovative Strategies for Personalized Immunotherapies and Reservoir Eradication

PROJECT SUMMARY/ABSTRACT
Antiretroviral therapy (ART) is highly effective against HIV-1 and has saved millions of lives. However, ART is
not curative, and people living with HIV (PWH) require life-long therapy because they harbor integrated
replication-competent proviruses that quickly fuel rebound when ART is discontinued. This reservoir of infected
cells represents the major barrier to long-term ART-free HIV-1 control, and interventions aimed at decreasing or
eliminating them remains a priority. A growing body of evidence shows that the intact, rebound-competent HIV-
1 reservoirs evolve over time in response to ongoing immunologic pressure. Importantly, reservoir composition,
integration landscapes and transcriptional activity are variable among PWH. These observations highlight the
need for tools to carefully characterize bona fide reservoirs and identify key drivers of persistence to tailor
approaches that are more likely to effectively perturb reservoirs, and prevent the return of viremia upon ART
cessation. The object of the proposed program – “INSPIRE: Innovative Strategies for Personalized
Immunotherapies and Reservoir Eradication” – is to tailor a combination of immunologic approaches that disrupt
latency and enhance cellular and humoral responses to effectively control or eliminate rebound competent
reservoirs in vivo. The program will leverage new methods our groups developed to generate engineered and
authentic reservoir CD4+ T-cells clones and engineer B cells to produce broadly neutralizing anti-HIV-1
antibodies. We will use the newly available technologies to characterize reservoirs of PWH, to define the rules
governing susceptibility of silent or transcriptionally active intact proviruses to latency reversal and cell-mediated
killing, and perform proof of concept experiments to suppress SHIV-1 infection long-term in the absence of ART.
These technologies will be applied to categorize ‘reservoir types’ and to select interventions most likely to
eliminate reservoir clones in an individual or individuals with similar ‘reservoir types’. Our program is structured
in three Research Focus Areas: (1) Apply and improve platforms to isolate authentic clones of CD4+ T-cells
carrying latent HIV-1 proviruses and produce engineered reporter CD4+ T-cell clones representing varied
responses to bNAb therapy and use these reagents to tailor therapeutic strategies, including the selection of
new clinically viable latency reserving agents, (2) Assess elimination of reservoir clones by tailored cytotoxic T
lymphocytes (CTL)- and natural killer (NK)-based approaches and link to in vivo impact of broadly neutralizing
antibody (bNAb) treatment, and (3) Engineer long-lasting, high-level expression of bNAbs to control established
simian-human immunodeficiency virus (SHIV) infections as proof of concept towards tailored HIV-1 control.

Public health relevance
PROJECTIVE NARRATIVE Despite the success of antiretroviral therapy (ART), people living with HIV (PWH) require life-long therapy because the virus can persist in a long-lived reservoir of latently infected cells. Interventions aimed at eliminating or controlling HIV-1 in absence of ART remain a priority but the nature of HIV-1 reservoirs is variable among PWH which poses challenges to developing broadly effective cure strategies. Careful characterization of these reservoirs will enable development of individually tailored therapeutic approaches that take this variability into account, allow reservoir control or elimination, and prevent the return of viremia and symptomatic disease in individuals upon ART cessation.